Subcortical influence on the respiratory coordination of cortical neurodynamics related to cognition

Slow cortical oscillations, such as theta (5-9Hz) band activity, may provide coherence of activity over large
distances, providing a mechanism for interregional communication involved in neural processing. Faster
gamma band oscillations (GBO; 30-200 Hz) are thought to play a major role in higher-level cognitive
processing including attention. The role of theta/GBO coupling (TG coupling) in cognitive processing is well
established. However, more recent studies have observed that nasal respiration can also temporally
coordinate dynamic neural activity in the brain, reflected as respiratory-entrained oscillations (REO), which
exhibit high phase-amplitude coupling to GBO (RG coupling) during select behaviors. Presently it is unknown
if RG coupling has a role in cognition. Our overarching hypothesis posits that the strength of RG coupling in
the attention-related frontoparietal network (prelimbic and posterior parietal cortices) will correlate with
attention-related performance.
Aim 1: RG coupling in the frontoparietal attentional network correlates with performance in an
attention-demanding operant task. We will measure respiration and REO in local field potentials in select
brain regions to evaluate RG coupling during an operant signal detection task used to measure sustained
attention, the rodent psychomotor vigilance task (rPVT). In the rPVT, mice maintain attention to a stimulus
location, and respond to detection of a brief and unpredictable cue with a short-latency operant response to
receive food reward. Prior to correct trials, we predict that RG coupling will be strong in the frontoparietal
attention network, and that fast reaction times will correlate with robust RG coupling. In contrast, prior to
omission trials (attention failures), we predict that RG coupling will be diminished.
Aim 2: Attenuation/promotion of RG coupling by means of optogenetic manipulation of BF
parvalbumin neurons (BF-PV) will impair/improve attention-related performance in the rPVT. Our
preliminary findings show that closed-loop gamma frequency stimulation (CLS) of BF-PV in relation to
respiratory inhalation, but not exhalation, promotes RG coupling. Therefore, we will utilize this CLS paradigm to
determine how modulation of RG coupling impacts attention-related performance.
Across a range of select neuropsychiatric illnesses, the pathological processes behind cognitive deficits
involve abnormal neural temporal dynamics. Thus, these studies will help to inform the development of
translational therapies to restore/enhance cognitive function.

Public health relevance
Abnormalities in the temporal modulation of neural dynamics have been associated with cognitive deficits. Recent studies have observed that nasal respiration can temporally coordinate dynamic neural activity in the brain, reflected as respiratory-entrained oscillations, which exhibit a high degree of phase-amplitude coupling to gamma band activity. The broad objective of this proposal is to provide a better understanding of respiration- entrained oscillations, and their coupling to high-frequency gamma band oscillations, during sustained attention, which may inform novel treatments of the cognitive deficits seen in select neuropsychiatric disorders these disorders.